Disentangling specific and off-target signals in tau PET imaging

PROJECT SUMMARY
Positron emission tomography (PET) imaging of tau aggregates plays an increasingly important role in the
diagnosis of Alzheimer’s disease (AD) and other tauopathies, and has provided new insights into the
pathophysiology of these diseases. Promising tau radiotracers have been developed, however they all suffer
from important limitations due to off-target binding either in brain regions directly implicated in the disease
process or in adjacent regions. We propose to develop a new approach based on factor analysis of dynamic
sequences to remove the contribution of this contaminating signal to the PET measurements. We expect our
approach to improve our ability to quantify small signal changes in tau aggregates in key brain regions, which in
turn should improve our ability to diagnose AD in early stages, to detect changes in longitudinal studies and to
monitor responses to future therapeutics. We will characterize the performance of the proposed method in
computer simulations and will evaluate the technique in experimental measurements acquired in healthy
controls, subjects with mild cognitive impairment (MCI) and AD patients.

Public health relevance
PROJECT NARRATIVE All positron emission tomography (PET) radiotracers developed thus far for in-vivo imaging of tau aggregates, an important biomarker of Alzheimer’s disease (AD) and other tauopathies, demonstrate some off-target binding that may seriously limit the clinical and research utility of those tracers. We propose the development of a methodology based on factor analysis of dynamic sequences to disentangle the contribution of tau-specific and off-target components to the measured PET signal. If successful, our approach will facilitate more accurate quantification of tau aggregates in key brain regions, which in turn will improve our ability to diagnose AD in early stages.